Targeted Protein Degradation

ABSTRACT
Support is requested for a Keystone Symposia conference entitled Targeted Protein Degradation, organized by
Drs. James Bradner, Eric Fischer and Brenda Schulman. The conference will be held in Keystone, Colorado
from January 29- February 1, 2023.
This Keystone Symposia conference will focus on advances in the rapidly evolving field of targeted protein
degradation (TPD). Over the past five years, the field has moved from proof of concept to the development of
degrader drugs in clinical trials. Clinical impact has brought a sense of urgency and broadened interest for
formulating and clarifying a new science of degradation. TPD has focused on cullin ring ligases and their
substrate receptors, cereblon and VHL, along with other degradation pathways such as autophagy, ERAD,
heat shock chaperones and monovalent degraders that are emerging as part of the TPD field. Currently small
molecule degraders induce the formation of non-native protein-protein interactions. Elucidation of mechanistic
details that drive ternary complex formation, and the timely sharing of these discoveries, are critical to give the
field momentum and drive it forward. This Keystone Symposia conference will invite leaders in the field, from
around the world, to share insights across diverse disciplines that will provide insight into the biophysics,
chemistry, cell biology and genetic basis for this new science. There will a strong emphasis on renewing the
spirit of face-to-face exchanges among subject matter experts with the idea to maximize interactions, formulate
questions and foster new collaborations.

Public health relevance
PROJECT NARRATIVE Targeted Protein Degradation (TPD) describes the cell’s natural protein destruction machinery that is brought together by a molecule and a protein of interest that eventually becomes degraded through cellular processes. The field has seen enormous progress over the last few years but the potential of TPD remains largely untapped for many therapeutic targets. This conference will bring together the current ‘state of the art’ thinking and forge the connections between scientists equipped to address the challenges in the field and define the new frontiers of TPD drug discovery.